ELECTRICAL PACING FOR PREVENTION OF UPPER AIRWAY OBSTRUCTION DURING SLEEP

These studies will test the feasibility of functional electrical stimulation of pharyngeal muscles to prevent or reverse obstructive sleep apnea.